Leveraging Digital Health Solutions to Reduce Learning and Functional Disparities in Children with Cancer - Administrative Supplement

PROJECT SUMMARY/ABSTRACT
Administrative Supplements on Long-Term Cancer Survivorship. While childhood leukemia and lymphoblastic
lymphoma therapies have achieved remarkable cure rates, they have created a growing population of survivors
facing persistent treatment-related neurocognitive, academic, and related functional challenges into adulthood.
To address these long-term effects, we developed and have iteratively refined a high-intensity intervention
program (HIP) that, unlike traditional child-directed interventions (which have not yielded long-lasting
improvements), takes a parent-directed approach, equipping parents with evidence-based tools to support their
children’s learning and academic success. The parent randomized controlled trial (R01CA261793) evaluates our
fourth iteration of HIP: HIP-eHealth, which delivers parent training remotely from a single site (City of Hope) and
guides parents in supporting their children’s academic progress through use of the award-winning online learning
platform IXL. In the parent study, survivors of childhood leukemia and lymphoblastic lymphoma and their parents
(target: N = 166 dyads) are randomized to HIP-eHealth or a lower-intensity, single session mimicking usual care
provided to survivors of pediatric brain tumors (LIP). HIP-eHealth has shown promising early results, with high
completion rates and positive parent reports of increased self-efficacy and improved child academic outcomes.
However, preliminary data from 133 currently enrolled parent/child dyads has revealed unexpected challenges
emerging from the introduction of IXL. IXL’s curriculum-based assessments in Math and English Language Arts
have revealed that 56% of children randomized to HIP-eHealth are performing at least two grades below their
actual grade level. Such substantial academic gaps cannot be effectively closed without sustained practices
extending well beyond active intervention, after external support concludes and families transition to
independence. Unfortunately, many parents have required far more study team support than expected to
facilitate consistent IXL engagement. Understanding the factors influencing sustained, independent parental
engagement vs. reliance on external support is crucial for optimizing intervention effectiveness and ensuring
long-term academic gains. In this project, we will conduct semi-structured interviews with 30 parent/child dyads
(N = 60 total participants) who completed HIP-eHealth, strategically sampling families who required high study
team support vs. those who demonstrated independent engagement in IXL. In Aim 1, we will identify parental
beliefs and contextual factors influencing parents’ sustained engagement in their children’s academic support.
In Aim 2, we will examine child perspectives on intervention components and factors contributing to continued
use of academic strategies and practices post-intervention. This research will provide essential context for
interpreting parent study findings and transforming our descriptive observations of variable parent-child
engagement patterns into actionable insights critical for scaling HIP-eHealth effectively.

Public health relevance
PROJECT NARRATIVE This supplemental research project addresses critical gaps in understanding how families of childhood cancer survivors navigate the long-term cancer- and cancer treatment-related learning and academic challenges that can impair educational attainment and quality of life into adulthood. While our ongoing HIP-eHealth intervention shows promise for improving learning and academic outcomes in childhood leukemia and lymphoblastic lymphoma survivors, implementation has revealed unforeseen barriers to sustained family engagement in academic support practices. By systematically investigating parental beliefs, contextual factors, and child perspectives influencing family engagement during and after HIP-eHealth, this study will provide essential insights to optimize intervention design for lasting effectiveness and broader implementation among the growing population of childhood cancer survivors.